COPD cachexia: deciphering the impact of antioxidants, iron and mitochondrial function using 'omics approaches

SUMMARY
Chronic Obstructive Pulmonary Disease (COPD) is the fourth leading cause of death in the United States
with mortality continuing to rise despite advances in medicine. Cachexia, a form of muscle wasting, is a
debilitating co-morbidity whose prevalence increases with severity of COPD. But, cachexia still occurs among
COPD patients with milder disease severity. Cachexia is most often thought of with respect to cancer. However,
by population prevalence there are more COPD patients with cachexia than cancer patients with cachexia. Yet
there have been few studies investigating the etiology of COPD cachexia underscoring the need for
investigations of COPD cachexia and weight-loss. Accumulating data including our own points to a role for iron
toxicity in the etiology of COPD cachexia. Heme is an essential component of mitochondrial cytochromes
providing protection from reactive oxygen species (ROS). Defects in heme biosynthesis cause buildup of free
iron, ROS and mitochondrial dysfunction. Buildup of free iron leads to iron toxicity and production of ROS
particularly in the absence of adequate intake of antioxidants such as Vitamins E. As such, our overarching
hypothesis is iron toxicity in COPD cachexia is driven by impaired antioxidant and mitochondrial function. This
study has three specific aims: 1) To determine whether genomic variation associated with the absorption and
regulation of Vitamin E is more common in COPD cachexia; 2) To assess whether plasma Vitamin E in subjects
with COPD cachexia are associated with impaired mitochondrial function; Exploratory Aim) To test whether
iron induced transcriptional dysregulation signatures in myoblasts are preserved in transcriptomics signatures
associated with COPD cachexia in skeletal muscle biopsies. Elucidating mechanisms of mitochondrial
dysfunction in COPD cachexia has the potential to aid the development of therapeutics targeting mitochondrial
oxidative stress. As future research, we plan to test whether ‘omic regions and metabolites identified as
associated with COPD cachexia directly effect pathways involved with Vitamin E and mitochondrial function
using targeted assays in myoblasts or other appropriate systems.

Public health relevance
PROJECT NARRATIVE/ PUBLIC HEALTH RELEVANCE STATEMENT Chronic Obstructive Pulmonary Disease (COPD) is the fourth leading cause of death in the United States with mortality continuing to rise despite advances in medicine. Cachexia, a form of muscle wasting, is a debilitating co-morbidity whose prevalence increases with severity of COPD. Elucidating mechanisms of mitochondrial dysfunction in COPD cachexia has the potential to aid the development of therapeutics targeting mitochondrial oxidative stress.